Utilizing senolytics to enhance the response to exercise in cachectic mice

Project Summary. Skeletal muscle mass and function are key determinants of an individual’s healthspan and
are tightly correlated with both physical and metabolic health. In cancer survivors, the loss of muscle mass that
occurs following cancer, termed cancer cachexia, is a major contributor to mortality, as well as reduced quality
of life during and after the disease. Unfortunately, one of the most extensively used treatments for cancer
patients, chemotherapy, is almost as bad as the cancer itself due the negative effects that chemotherapy has
on healthy cells. Chemotherapy treatments such as cisplatin, induce DNA damage, thereby compounding an
already deleterious process in healthy tissues and cells. Severe or unrepaired DNA-damage causes cell death
and tissue atrophy, in addition to being a major inducer of cellular senescence. Recent work by our lab has
linked an accumulation of senescent cells as a novel contributing factor to cisplatin-mediated loss of muscle
mass and function. In response to cisplatin, there is an accumulation of senescent cells in muscle, which is
correlated to a reduction in muscle fiber cross-sectional area. Considering senescent cells have been linked to
sarcopenia, removal of these senescent cells using senescent cell killing compounds, senolytics, could help
slow muscle loss during cisplatin treatment. Exercise training is the most effective way to increase skeletal
muscle mass, in addition to improving physical function and whole-body metabolism. Following chemotherapy
treatment, the response to exercise is attenuated (termed anabolic resistance), and individuals treated with
chemotherapy following surgery have a blunted response to exercise compared with surgery alone. Given that
elimination of senescent cells augments muscle growth and regeneration in old mice, senolytics could serve as
a novel therapeutic intervention to not only delay cisplatin-induced atrophy but also improve the response to
exercise training. Our central hypothesis is that cisplatin-treated mice receiving senolytics will experience less
atrophy and an augmented response to exercise when compared to controls. We will utilize the plant-based
flavonoids, fisetin and quercetin (F+Q), as our senolytic cocktail. In addition to their excellent senolytics
properties, F+Q exert many other beneficial effects, such as antioxidant and anti-inflammatory, and promoting
mitochondrial biogenesis. To address our hypothesis, we will pursue three specific aims: 1) delete senescent
cells in mice treated with F+Q to determine if cellular senescence mediates cisplatin-induced muscle atrophy,
2) examine senescent cells as contributors to anabolic resistance following progressive weighted wheel
running, and 3) characterize the cellular landscape and identify the molecular signature of muscle senescent
cells. We will utilize an age-appropriate mouse model to identify the therapeutic potential of senescent cells to
slow both the physical and metabolic aspects of chemotherapy-induced cachexia and anabolic resistance. If
our hypothesis is correct, the results from our proposed studies could influence the treatment of cachexia and
associated metabolic derangement, thereby creating new interventions and therapeutic strategies.

Public health relevance
Project Narrative Chemotherapy treatment is associated with a loss of muscle mass and resistance to adaptations to exercise, which are among the most impactful physiologic conditions that survivors face. Although there are various mechanisms by which chemotherapy can negatively affect muscle mass and function, we hypothesize that an accumulation of senescent cells inside of skeletal muscle is a powerful, but under-studied, contributor. Providing insight into the mechanisms driving muscle wasting during cachexia, as well as its treatment, could lead to creative therapeutic avenues to help preserve or restore muscle health and improve quality of life.